Diversity Action Plan: UW GenOM Project

ABSTRACT The overarching goal of the UW GenOM Project is to sustain and continue to develop a comprehensive umbrella program for undergraduates at the University of Washington to coordinate recruitment, retention and training activities for groups that are significantly underrepresented in genomic sciences and genetic medicine. The program will focus on Blacks/African Americans, Hispanic/Latinx Americans, Native Americans, Alaska Natives, Native Hawaiians, and Pacific Islanders. Additional emphases will be on serving students who come from disadvantaged backgrounds (rural, low income, students with disabilities, and those who come from low resource schools). The proposal will build upon the success of the UW GenOM Project to date, affiliated on- campus resources for underrepresented minority and underserved students, as well as the expertise of the scientists and faculty in the University of Washington’s department of Genome Sciences, the UW Genome Training Grant, other NIH-funded research centers and training grants, and other relevant departments on campus. The program will increase the numbers of genomic-science focused students from underrepresented minority and underserved populations who graduate with a bachelor’s degree and matriculate into graduate programs in genomic sciences, genetic medicine, and allied fields.

Public health relevance
NARRATIVE The goal of the UW GenOM Project is to recruit, train, and retain underrepresented, underserved and disadvantaged undergraduates in genomic science and genetic medicine fields relevant to NHGRI’s mission. This proposal will build upon the success of the UW GenOM Project, its partners, and the mentoring and science expertise of the faculty at the University of Washington, particularly the faculty in the UW Genome Training Grant. This program, if funded, will increase the numbers of genomic-science focused undergraduates from underrepresented, underserved and disadvantaged populations who will be competitive for admission to graduate school.